SMART-SEPSIS: Sequential MAchine learning for individualized Response to early Treatment in lung SEPSIS

TITLE OF PROPOSED STUDY: SMART-SEPSIS: Sequential MAchine learning for
individualized Response to early Treatment in lung SEPSIS
Title
Sequential MAchine learning for individualized Response to early Treatment in lung
SEPSIS
Abstract
Lung infection is the most frequent cause of sepsis and accounts for more than 40% of cases of
acute respiratory failure. Among patients with pneumonia and sepsis, any delay in initiating the
treatment increases the risk of respiratory failure and death. The hour-1 sepsis bundle
recommends obtaining blood cultures and lactate measurement, initiating antibiotics, fluid
resuscitation, and potentially vasopressors within the first hour. Hospital compliance with these
guidelines remains moderate at 60%. The response to each element of the sepsis bundle is
heterogeneous. While early treatment is desirable, indiscriminately exposing patients with
suspected lung sepsis to antibiotics, fluids and/or vasopressors carries some risk. At the bedside,
clinicians’ acumen, albeit augmented by early warning systems (EWSs), and machine-learned
(ML) sepsis prediction algorithms is not sufficient to accurately identify lung sepsis and
discriminate which patient should receive the hour-1 bundle. Thus, there is an unmet need to
precisely select lung sepsis patients who will benefit from immediate application of the hour-1
bundle to reduce their risk of organ dysfunction, including respiratory failure and/or death.
Our central hypothesis is that electronic health record (EHR) data and artificial
intelligence/machine learning (AI/ML) can be used to model the individual response to sepsis
treatment and promote an early but reasoned application of the hour-1 bundle in patients with
suspected community-onset lung sepsis (COLS).
We will use existing EHR data from 3 integrated health systems (UCSF, UPenn and UPMC) to
train (Aim 1a), externally validate (Aim 1b), prospectively and silently test (Aim 2a) a real-time,
interpretable clinical decision support system (CDSS) to guide early treatment in patients with
suspected COLS. Our CDSS will derive from the estimated individual treatment effect (ITE) of
antibiotics, fluid resuscitation and vasopressors. To optimize the acceptability by the clinician and
the feasibility of a future clinical trial, we will design an EHR-embedded user interface that will
provide a treatment recommendation based on the estimated ITE with a degree of confidence.
(Aim 2b) We will iteratively improve its design using structured feedback from the clinicians.
This research will allow us to identify the patients who should receive each individual element of
the hour-1 bundle. Based on the previously reported impact of early treatment on organ
dysfunction, including respiratory failure and mortality in patients with sepsis, this research has
the potential to decrease mortality, morbidity and reduce inappropriate interventions among
patients with COLS.

Public health relevance
Project Narrative Among patients with severe lung infection, minimizing the time-to-treatment is crucial to decrease the risk of respiratory failure and death. However, delays in treatment are frequent, and starting these treatments indiscriminately in patients with suspected lung sepsis is also associated with risks. In this proposal, we will use data from the electronic medical records and artificial intelligence to build a clinical decision support system based on the predicted individual response to early treatment, with the goal of reducing morbidity and mortality in patients with severe lung infections.